Community Outreach and Engagement

PROJECT SUMMARY - COMMUNITY OUTREACH AND ENGAGEMENT (COE)
The Ohio State University Comprehensive Cancer Center (OSUCCC) is a national and international leader in
translational research, with a reputation for delivering high-quality patient care and effective outreach and
education programs to residents of the state of Ohio - our catchment area (CA) - and beyond. The CA includes
all 88 counties in Ohio, which have very diverse populations, with many underserved communities as well as
urban, rural and Appalachian communities. Electra Paskett, PhD, MSPH (CC) Associate Director for Population
Science and Community Outreach and Director of the Center for Cancer Health Equity (CCHE) leads the
Community Outreach and Engagement (COE) efforts for the OSUCCC. The CCHE is at the core of our COE
efforts supporting the OSUCCC mission to reduce cancer health disparities throughout the CA. The CCHE is co-
led by Darrell Gray II, MD, MPH, FACG (CC), who oversees the COE initiatives with the Clinical Trials Office to
improve the accrual of women and minorities to clinical trials. COE works in the CA to connect minority
populations to screening, outreach and engagement services. They also work with basic, clinical and population
science program leaders in the OSUCCC to cultivate interest in CA-focused research including working with the
Government Relations team and key faculty across the Center to pursue policy initiatives that address the cancer
burden. COE efforts are supported by two Community Advisory Boards (rural and urban) that inform the focus
and scope of CCHE activities and provide ongoing feedback to the OSUCCC leadership and Program leaders.
The high priority cancers for the OSUCCC include lung, breast, colorectal, prostate, endometrial, cervical cancer,
thyroid, and leukemia, as well as tobacco use, obesity and HPV vaccination. OSUCCC research and/or outreach
and engagement efforts are ongoing to address these priority areas, via partnerships between the COE,
OSUCCC research program members, and the community. To assess the impact of COE and OSUCCC efforts
we have developed a logic model that includes short-term metrics of COE success: expanded reach (community
members, patients); impact (services provided, time to diagnosis); collaborations (community partners,
researchers); initiatives (grants funded); and clinical trial accrual (especially of underrepresented populations);
and long-term metrics success including: reduced prevalence of risk factors and cancer rates, and longevity and
impact of community partnerships. Over the last five years, we have had significant impact on HPV vaccination
rates, accrual of minorities to clinical trials, breast cancer detection rates, navigation to screening and treatment,
implementing translation for non-English speaking patients, fostering research to address the cancer burden in
the CA. COE future plans focus on the priority cancers/risk behaviors of the OSUCCC as well as on 1) ensuring
adequate communication between the community and the OSUCCC researchers as it relates to addressing the
cancer burden in the catchment area and 2) a focus across the lifespan and expand to populations we are just
beginning to work with (Asian, pediatric, rural clinics, LGBTQ) in order to reduce the cancer burden in our CA.